The Causal Impact of Poverty Reduction on Housing Conditions of Low-Income, U.S. Children and the Role of Housing and Neighborhood Ecosystems on Young Children's Healthy Development

1 PROJECT SUMMARY/ABSTRACT
2 The increasingly limited availability of affordable housing paired with a shortage in provision of federal rental
3 assistance among eligible families means millions of low-income, U.S. children live in unstable and/or substand-
4 ard-quality housing – conditions which have been linked to a range of adverse child health and development
5 outcomes. The lack of affordable housing in low-poverty neighborhoods further contributes to families living in
6 crowded housing conditions and/or residing in neighborhoods that expose children to stressful, unsafe environ-
7 ments. Although infants and toddlers experience the highest rates of childhood poverty and spend a substantial
8 portion of their time at home, there exists little evidence assessing the impact of adverse housing and neighbor-
9 hood conditions specifically on the health and development of this age group. Moreover, as less than 25% of
10 eligible, low-income families with young children receiving housing assistance, there is need to understand
11 whether other anti-poverty programs can help improve housing conditions for these children and their families.
12 The proposed research seeks to address these knowledge gaps and provide scientific evidence to inform
13 the design of anti-poverty programs that aim to improve early housing and neighborhood environments for low-
14 income children. By using data from Baby’s First Years (BFY) – a randomized control trial evaluating the impact
15 of a monthly, unconditional cash transfer (UCT) to low-income, U.S. mothers and their young children (NICHD
16 R01HD087384) – this research will provide a rich understanding of the housing and neighborhood ecosystems
17 low-income infants and toddlers (0-3 years) inhabit and how these environments impact their healthy develop-
18 ment. Aim 1 estimates the causal impacts of the UCT on housing affordability, composition, stability, and quality
19 using a multivariate linear regression model. Aim 2 conducts latent class analysis using the control sample to
20 identify configurations of housing and neighborhood ecosystems experienced by BFY participants and then eval-
21 uates how these configurations influence young children’s (0-3 years) physical health, use of medical care, be-
22 havioral and socioemotional development, and language acquisition. Aim 3 investigates the mediating role of
23 housing and neighborhood conditions on young children’s healthy development using the same outcome
24 measures as Aim 2.
25 This fellowship application is designed to provide the PI with training in advanced statistical methods
26 critical for conducting policy and public health research, as well as opportunities to maximize the policy relevance
27 of her work, gain further clinical experience, and build professional skills critical to success as an academic
28 scholar. Her proposed research, training plan, and highly qualified, interdisciplinary mentorship team will ensure
29 she is well-positioned to achieve her long-term goal of becoming an independent physician-scientist dedicated
30 to using rigorous, policy-driven research to improve the health and well-being of children and their families.

Public health relevance
PROJECT NARRATIVE Over half of all low-income, U.S. children live in unaffordable, unstable, and/or substandard-quality housing, which has been linked to a range of adverse child outcomes; however, little is known about the impact of these housing conditions on infants’ and toddlers’ health and development, how housing and neighborhood environments interact to influence young children’s healthy development, and whether other anti-poverty programs can improve housing circumstances for low-income families with young children. Using data from the NICHD-funded (R01HD087384) Baby’s First Years (BFY) study – a large-scale randomized control trial evaluating the impact of a monthly, unconditional cash transfer (UCT) to low-income mothers – I will study how a UCT impacts housing affordability, composition (i.e., who lives in the household), stability, and quality among low-income families with infants and toddlers, the configurations of housing and neighborhood ecosystems experienced by low-income families, and how housing and neighborhood characteristics impact young children’s healthy development. Results from this proposal will offer new insights into how early childhood housing and neighborhood conditions interact with family economic resources to shape children’s health and development trajectories, as well as inform the design of anti-poverty programs aimed at improving early childhood environments.